High-throughput small molecule screen to reduce endogenous level of Msh3 for disease-modifying HD therapy

PROJECT SUMMARY
Huntington's disease (HD) is an inherited neurodegenerative disorder caused by a CAG-repeat expansion
encoding mutant Huntingtin (mHTT). Recent genome-wide association studies (GWAS) identified 10 genomic
loci significantly modifying the age-of-onset or progression of HD. These loci are significantly enriched with DNA
repair genes, including four DNA mismatch repair genes (Msh3, Mlh1, Pms1 and Pms2). Our mouse genetic
study demonstrated that Msh3 deficiency significantly reduced mHtt aggregates and rescued mHtt-induced
transcriptionopathy in Q140 knockin mouse model of HD. Our research initiative focuses on developing novel
therapeutic strategies for HD by targeting the Msh3 protein. Leveraging a multi-faceted approach, we have
established a robust screening pipeline utilizing a newly developed knockin mouse model expressing a
luciferase-based reporter of endogenous Msh3, enabling high-throughput screening of small molecules that
modulate Msh3 levels in cellular models. In the R61 phase, we aim to demonstrate the scalability, precision, and
reproducibility of our primary mouse embryonic fibroblast (MEF)-based Msh3 reporter assay (Aim 1) and
subsequently develop secondary assays to further interrogate and eliminate less desirable chemical hits (Aim
2). These assays include directly measuring endogenous MSH3 RNA and protein levels in human a human cell
line, examining Msh3 lowering efficacy with a therapeutically relevant cell type (primary striatal neuron), and
assessing the functional consequence of lowering MSH3 in cells. In the R33 phase, we will utilize the MEF-
based Msh3 reporter assay optimized in Aim 1 to conduct a large-scale screening of 300,000 chemically diverse
compounds to identify potential Msh3-lowering modulators. Subsequently, we will establish a testing funnel with
the assays developed in Aim 1 and 2 to gradually eliminate and prioritize the hits and chemical scaffolds to
identify potential leads. Throughout these endeavors, rigorous authentication of biological and chemical
resources will be ensured, aligning with our commitment to scientific integrity. Through this comprehensive
approach, we aim to identify lead compounds with therapeutic potential for HD and potentially other
neurodegenerative diseases sharing similar MSH3-dependent, repeat-expansion related pathogenic
mechanisms, ultimately advancing towards effective disease-modifying treatments.

Public health relevance
PROJECT NARRATIVE Our project aims to address the urgent need for disease-modifying therapies for Huntington's disease (HD), a devastating neurodegenerative disorder characterized by progressive neuronal loss. Building on recent findings from HD Genome-wide Association Studies (GWAS) that certain DNA repair gene variants may modify the onset of HD, our robust in vivo research showed that genetic reduction of mismatch repair genes (especially Msh3) confers robust gene-dosage-dependent suppression of disease phenotypes in HD vulnerable striatal and cortical neurons. By utilizing our innovative cell-based reporter system and a suite of secondary assays, we will conduct high-throughput screening to identify small molecules capable of reducing the protein levels of murine Msh3 and human MSH3, with the ultimate goal of identifying novel therapeutics to treat HD.